Training in Demography

PROJECT SUMMARY
The Population Studies and Training Center of Brown University (PSTC) requests continuing support for its
T32 National Research Service Award. The long-term goal of the PSTC Demography Training Program is to
prepare predoctoral and postdoctoral social scientists to become internationally renowned population
investigators and scholars. More concretely, our objectives are to promote research, publication, and grant
funding among trainees during and after training. We request support for five predoctoral trainees and one
postdoctoral trainee. In this application, we provide evidence of a strong interdisciplinary training program,
supported by productive, committed faculty, focused on training doctoral candidates and postdoctoral fellows
from Anthropology, Economics, Sociology, and Public Health. We demonstrate that the PSTC training program
shows ample evidence of continued intellectual and organizational evolution and dynamic synergy across
disciplines and career stages, from new trainee through senior scholar, and a commitment to excellence that
will produce the highest quality population science scholars. We show excellent recruitment, retention and
placement outcomes in the previous grant period, and we focus on maintaining this excellence while improving
professionalization and enhancing young scholars’ paths to future independence with this new application.
The PSTC training program proposed here builds on a dynamic research infrastructure. Guided by the NICHD
mission to support research, data collection, and research training in demography, reproductive health, and
population health, the PSTC makes distinctive intellectual contributions in five primary areas: Migration and
Urbanization; Population, Development, and Environment; Children, Families, and Health; Reproductive Health
and HIV/AIDS; and Social Foundations of Health Disparities. PSTC research is methodologically broad and
innovative, with unique contributions to methods in anthropological demography, spatial and contextual
approaches, and research design and causal inference. Predoctoral and postdoctoral trainees are integrated
into all these areas. Their training is advanced through coursework, mentored research, working groups,
colloquia, methods modules, and professionalization workshops. We show evidence of major institutional
support in the form of physical space, significant investments in graduate education generally, and targeted
funds to support trainees. Predoctoral trainees are typically selected for T32 funding for one or two years
during second or third year of graduate school. An active Training Committee supervises the design of the
program and coordinates with our participating departments. The Training Director supports the day-to-day
operation of the program. We describe both continuing and innovative organizational and pedagogical efforts
to secure the training goals we outline in this application.

Public health relevance
PROJECT NARRATIVE Our training program mentors social scientists at the predoctoral and postdoctoral levels to become independent population investigators and scholars conducting responsible research to understand and improve global population health and well-being through articulating the critical contributions of the demographic, social, institutional, and environmental dimensions. The program actively recruits a diverse body of trainees to improve the representation of women, historically underrepresented groups, and other groups in the public health workforce.